Regulation of DNA replication by histone modifications

DESCRIPTION (provided by applicant): The broad, long term goal of the proposed study is to determine, at the molecular level, the mechanisms by which DNA replication occurs in vivo. Faithful duplication of the genome is essential for life. Any disturbance in this process can lead to genomic instability, unregulated cell growth or cell death. Therefore, studying the mechanisms of DNA replication will contribute not only to broad areas of basic biology, but also to understanding the molecular basis for human diseases, such as cancer and developmental disorders. DNA replication requires highly coordinated recruitment of replication factors to replication origins in a chromatin context. It is therefore expected that histone modifications around replication origins strongly affect DNA replication. Accordingly, there is supporting evidence for significant roles of histone modifications in replication. However, how histone modifications are regulated around DNA replication origins and how these modifications affect different steps of DNA replication still remain as important open questions. In the current funding cycle of this grant, we have developed an extremely efficient system to purify histones that are located near an active replication origin. Combined with ultra-sensitive mass spectrometry analyses, we identified previously unknown patterns of histone modifications that are present specifically around an active replication origin. Furthermore, we have shown that these modifications play important roles in DNA replication and/or cellular responses to replication stress. In this funding cycle, we propose to extend these findings to elucidate how these newly identified histone modifications function at the molecular level. PUBLIC HEALTH RELEVANCE: DNA replication and response to replication stress are conserved essential processes. Any abnormality in these processes can lead to cancer, developmental disorder or cell death. The goal of our work is to understand the molecular mechanisms of DNA replication and replication stress response, which will help understand the molecular basis for these disease states.

Public health relevance
Project Narrative DNA replication and response to replication stress are conserved essential processes. Any abnormality in these processes can lead to cancer, developmental disorder or cell death. The goal of our work is to understand the molecular mechanisms of DNA replication and replication stress response, which will help understand the molecular basis for these disease states.